Determining The Role of Photic and Non-Photic Time Cues in Resetting Lipid Circadian Rhythms in Humans

Project Summary/Abstract
Circadian rhythm disruption is experienced by patients with Circadian Rhythm Sleep-Wake Disorders and
millions of shiftworkers worldwide, which may increase their risk of developing chronic health disorders including
cardiovascular disease. Treatment of circadian rhythm disruption requires appropriately-timed intervention to
either shift the circadian system earlier (advance) or later (delay). A Phase Response Curve (PRC) informs when
to administer the intervention, without which the disruption may either be prolonged due to inadequate phase
resetting or worsened due to shifting the system in the wrong direction. Currently, the field relies on the PRC for
resetting the melatonin rhythm as guide to reset the entire circadian system, despite the fact that circadian
rhythms are present in many other physiological features besides melatonin. Our preliminary data show that
there are robust circadian rhythms in circulating levels of total cholesterol and triglyceride in healthy young
individuals and that these rhythms can also be shifted. Our pilot studies further indicate that the timing of these
lipid rhythms may be more responsive to shifts in the timing of meals rather than light exposure. We have
constructed preliminary PRCs of these lipid rhythms in response to a combined stimulus of light exposure and
meals distributed across the 24-h day and detected robust phase advances and delays. Moreover, the shifts in
these lipid rhythms are larger than those for melatonin. We do not know, however, whether light exposure or
meal timing is the primary time cue for resetting these lipid rhythms. Without this knowledge, developing a
comprehensive treatment for circadian rhythm disruption of lipid rhythms that likely underlies the cardiometabolic
consequences of shiftwork, will remain difficult. The objective of this proposal is to construct three PRCs that
systematically examine the contribution of light and meal timing on resetting lipid circadian rhythms. Young
healthy adults will be randomized to three conditions: (1) bright light + 12-h meal window, (2) dim light + 12-h
meal window, and (3) dim light + 6.5-h meal window (time redistricted eating), each distributed across the 24-h
day. The primary outcomes include phase resetting of lipid and melatonin circadian rhythms measured under
each of the three conditions, and the area-under-the curve of the lipids during the 6.5-h time restricted eating.
The aims of the study are to: (1) determine if light is the primary time cue for resetting melatonin but not lipid
circadian rhythms, (2) determine if meal timing is the primary time cue for resetting lipid but not melatonin
circadian rhythms, and (3) evaluate the acute effects of eating across the 24-h day on circulating lipid levels. Our
work will be a comprehensive evaluation of how two daily events – light exposure and meals – synchronize lipid
circadian rhythms in humans. We expect our analytic paradigm to be a foundational resource that can be
extended to future studies of other peripheral systems under circadian regulation in humans, and have a positive
public health impact by guiding therapeutic strategies for patients with circadian disruption and the population at
large, many of whom experience recurrent circadian disruption due to irregular sleep-wake schedules.

Public health relevance
Narrative Therapies for circadian rhythm disruption, which is common both in the general and clinical populations with irregular sleep-wake schedules rely on a single biomarker – the melatonin rhythm – to guide the timing of interventions such as bright light exposure even though circadian rhythms are ubiquitous across physiological systems. We have found that a combined intervention of light exposure and meals shifts the timing of the circadian rhythms in circulating cholesterol and triglycerides in humans, and we propose a randomized controlled trial in healthy young adults to determine the individual roles of light exposure and time restricted eating as the primary time cues for resetting the circadian rhythms of these lipids and melatonin, thereby construct phase response curves that define the relationship between the timing of these two interventions and the change in the timing of circadian rhythms in circulating lipids and melatonin. The knowledge gained will provide novel insight on the fundamental properties of the human circadian system and have potentially broad public health and clinical implications including recommendations for developing healthy light exposure and eating schedules and guiding current and future treatment strategies to address circadian disruption in multiple circadian systems.